ISES 2024 Annual Meeting

Abstract
The International Society of Exposure Science (ISES) is the premier international society devoted to bringing
the full value of exposure science to research and decision-making to improve human health and the
environment. This conference represents the most comprehensive gathering of environmental exposure
scientists and environmental health professionals from academia, government, and organizations from
around the world, reflecting the interdisciplinary nature of the field. The theme of the 34th ISES Annual
Meeting is “Exposures that Impact Health in Vulnerable Populations”. The 2024 conference will focus
on new and emerging environmental health challenges for humans and the ecosystem. Environmental
exposures may affect human health and the ecosystem in complex and non-linear ways. Exposure and
health issues also vary between local, regional, and global scales. Understanding the complex nature of
environmental exposures, the health impacts, and relevant strategies and policies to improve environmental
health requires the knowledge, analytical methods, and data collection tools developed from multiple
disciplines and applied at different scales. 2024 Meeting topics include application of sensors in exposure
assessment, citizen science and community-engaged research, climate change impacts on human
exposure, COVID-19, vulnerabilities in environmental exposure and health, new and emerging environmental
exposures, exposure data to policy action and impacts of public health policy, multiple exposures and
interactions, risk communication, statistical methods in exposure science and epidemiology, and
technology/sensors among others. There will be an added focus on environmental justice and
community engaged research as it relates to the field of exposure science. The 34th ISES annual
conference will be held in Montreal, Canada from October 20 - 24 , 2024 and will continue the success of
previous meetings. The meeting offers four and half days of cross-disciplinary presentations and discussions
of new research and methods of international, national, and regional significance and facilitates the exchange
of information and ideas among exposure science and environmental health scientists from academia,
government agencies, non-profit organizations, and industry. Conference attendance is expected to be
between 500-600 participants from North America, Europe, and Asia. ISES has encouraged attendance of
students and new researchers, as well as investigators from low- and middle-income countries over the last
6 years resulting in an average of 15% increase in the number of attendees. This proposal will support the
representation of students and new researchers from underrepresented backgrounds as well as provide an
opportunity for participation of community members, hence enhancing member diversity, promoting the
global development of exposure science, and fostering collaborations and information exchange both
nationally and internationally.

Public health relevance
Narrative The International Society of Exposure Science (ISES) is the premier international society devoted to bringing the full value of exposure science to research and decision-making to improve human health and the environment. This conference represents the most comprehensive gathering of environmental exposure scientists and environmental health professionals from academia, government, communities and organizations from around the world, reflecting the interdisciplinary nature of the field.